GATA Factor Function in Trophoblast

Abstract
Rodent and Human pregnancies are associated with a hemochorial placentation. Central to the hemochorial
placentation are two trophoblast cell types; (i) syncytiotrophoblasts (STBs), which establish an exchange surface
for nutrients and gases at the maternal-fetal interface, and (ii) a specialized population of trophoblast cells referred
to as invasive trophoblasts in rodents and extravillous trophoblasts (EVTs), in human. Invasive
Trophoblasts/EVTs invade into the maternal uterine tissue and modulate uterine cells, including immune
cells and endothelial cells to support continuation of pregnancy and proper development of the fetus.
Defective development and function of EVTs contribute to early pregnancy loss and pregnancy associated
complications such as preeclampsia and intrauterine growth restriction. Our published and unpublished
preliminary studies have established that GATA family transcription factors, GATA2 and GATA3, are
conserved in trophoblast cells, including in invasive trophoblasts, across mammalian species and are critical
regulators for mammalian placentation. The overarching goal of this proposal is to further define GATA
factor-mediated transcriptional mechanisms that regulate development and proper function of
specialized trophoblast cell types at the maternal-fetal interface and how defects in GATA factor
function contribute to pathological pregnancies.
Two specific aims are proposed. In Aim 1, We will study mutant rats, and mutant human TSCs, in
which GATA2 and GATA3 will be conditionally deleted and utilize state-of-the art genomics approaches to
test the hypothesis that GATA2/GATA3 establish conserved transcriptional program to regulate development
and function of invasive trophoblast/EVT lineage.
In Aim 2, we will test the hypothesis that defective GATA3 function in trophoblast cells contributes to
defective placentation in Trisomy 21 pregnancies. We will study placental tissues from chorionic villous
biopsies, patient-specific human trophoblast stem cells and mouse models, representing human Trisomy
21, to test this hypothesis.
Successful completion of proposed research will advance our knowledge about GATA factor-
mediated molecular mechanisms regulating development and function of the invasive trophoblast/EVT cell
lineage and whether impairment of those mechanisms could contribute to pathological pregnancies, such as
Trisomy 21.

Public health relevance
Relevance to Public Health: Defect in trophoblast lineage development results in early pregnancy loss or leads to pregnancies that are associated with intrauterine growth restriction or preeclampsia, which are leading causes of maternal death and premature birth. These are major public health concerns. One of the major causes for pathological pregnancies is defective development and function of trophoblast cell lineage, which assures embryo implantation and placentation. Therefore, a better understanding of trophoblast cell lineage development and function is critical to gain insights into important features of pregnancy loss and pregnancy associated disorders.